Epigenetic Programmers Targeted During Developmental Reprogramming

DESCRIPTION (provided by applicant): Exposure of cells or tissues to environmental stressors during critical periods of development can permanently reprogram normal physiological responses to increase susceptibility to disease later in life, a process termed developmental reprogramming. Developmental reprogramming is thought to occur via disruption of the epigenome, and is now appreciated to increase risk in adulthood for metabolic diseases, including obesity, diabetes, cardiovascular disease, and cancer. We were the first to identify non-genomic (or more accurately pre-genomic) signaling as a direct mechanism for endocrine disrupting chemicals (EDCs) to disrupt the epigenetic machinery and induce developmental reprogramming. Activation of kinases in pre-genomic signaling pathways that phosphorylate readers, writers and erasers is extremely attractive as a central mechanism for environmental stressors to engage the cell's epigenetic machinery. However, tremendous knowledge gaps remain in our understanding of how the epigenomic machinery is disrupted by pre-genomic signaling during developmental reprogramming. We do not know: 1) Which kinases/pre-genomic signaling pathways beyond PI3K/AKT are activated by obesogens in the liver (or other tissues); 2) Which epigenomic programmers are targeted by these kinases or how phosphorylation (or other PTMs) modifies their activity (up or down); nor 3) Which specific epigenetic marks placed on reprogrammed genes are altered to change gene expression and increase susceptibility to obesity (or other diseases) in adulthood. The goal of this application i to fill these knowledge gaps with a detailed mechanistic understanding of how EDCs utilize pre-genomic signaling to disrupt the epigenome, and to better understand how this developmental reprogramming alters metabolic set-points in the liver to promote obesity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Exposure to endocrine disrupting chemicals (EDCs) in early life can confer complex and long-lasting pathophysiological consequences later in life, including obesity. We hypothesize that EDCs induce this developmental reprogramming by engaging cell signaling pathways that post-translationally modify epigenetic "readers, writers, and erasers", and nuclear hormone receptor coregulators responsible for these epigenomic marks. Here, we will determine how four EDCs, relevant to human exposure, disrupt the normal function of epigenomic programmers and how this perturbation reprograms genes regulating metabolic "set-points" in the liver to promote obesity.